Visualization of extracellular morphogens to understand self-organized patterning

Project Summary
During embryonic development, extracellular proteins, known as morphogens, play a key role in conveying
positional information and establishing cell fates. While theoretical descriptions have posited plausible models
for how morphogens might shape embryonic development, until recently, quantitative experimental data have
been lacking. The Nodal pathway is essential for early development, and is necessary for stabilization of the
epiblast, specification of the mesendoderm, and formation of the left-right axis. Nodal and its inhibitors Lefty1/2
have long served as a model for tissue patterning by signaling activators and their cognate inhibitors, with several
studies suggesting that the Nodal-Lefty system generates self-organizing patterns via a Turing mechanism.
Unlike other TGFβ family members, Nodal has been found to signal as an obligatory heterodimer with a cofactor
(GDF1/3), and signaling requires a coreceptor (Cripto) in receiving cells in addition to the standard receptor
complex. There is some evidence for long-range dispersal of Nodal, particularly from overexpression studies,
and from studies of left-right axis specification, while recent studies of germ layer patterning in Zebrafish have
suggested that it functions at fairly short range over only a few cell tiers. We have taken advantage of CRISPR
editing in human pluripotent stem cells (hPSCs) to tag the Nodal gene with a fluorescent protein allowing us to
visualize it at endogenous concentrations for the first time. Using a self-organizing hPSC system that forms
patterns of different germ layers along the radial axis of an hPSC colony, we demonstrated that, in this context,
Nodal signaling is primarily autocrine and juxtacrine, signaling only to the immediate neighbors of producing
cells. This short-range signaling activity spreads via a relay mechanism in which Nodal producing cells signal to
their neighbors which causes them to transcribe Nodal protein and signal to the next layer of cells. This mode of
relay signaling has received much less attention than Turing mechanisms, even though it may operate in a
number of contexts in which signaling is short range. Here, we will build upon these tools and findings to perform
quantitative experiments and mathematical modeling to understand how the system of Nodal, and its inhibitors,
cofactors, and coreceptor functions in patterning. We will pursue three aims. (1) Understand how the relay
signaling system of Nodal and Lefty1/2 establishes dynamic patterns of signaling activity and cell fate (2)
Understand the role of cofactors and coreceptors in ligand dispersal and patterning. (3) Uncover how crosstalk
between Wnt and Nodal regulates signaling and cell fate. Together our studies will quantitatively probe how a
paradigmatic signaling system shapes fate patterns in the embryo during early development. As our experiments
are performed in human cells, our findings will shed important light on the role of these pathways in patterning
defects, as well as provide a foundation for manipulating signaling to created patterned tissues for regenerative
medicine.

Public health relevance
Project Narrative. While the components of key morphogen signaling pathways have been identified, a systems-level understanding of how signaling activity propagates and creates fate patterns is lacking. Here we take advantage of novel live cell reporters and human stem cell-based patterning systems to combine quantitative experiments with mathematical modeling to understand how the paradigmatic Nodal/Lefty pathway shapes cells fates in the early embryo. The results will be fundamental to understanding early embryonic development and provide a foundation for advances in preventing birth defects and in regenerative medicine.